Role of the Kinesin KIF1A in Neurological Disease

Mutations in the human kinesin gene KIF1A cause a variety of neurological defects. This syndrome has
remained poorly defined because of the rarity of the condition. This proposal brings together the very different,
but highly complementary expertise of Dr. Wendy Chung at Columbia University Medical School, a specialist in
human genetic disease; Dr. Richard Vallee, also at Columbia, an expert in the role of Kif1a in neuronal
development and physiology; and Dr. Arne Gennerich, at Albert Einstein College of Medicine, an expert in
motor protein biophysics. Dr. Chung's lab has developed clinical and computational methods to compile
information from patients locally and worldwide on the range, severity, and variety of symptoms associated
with this condition, which her lab has termed KAND KIF1A Associated Neurological Disorders. This is a heterogeneous group of severe neurodegenerative conditions, including spastic paraplegia, peripheral
neuropathy, optic nerve atrophy, cerebral and cerebellar atrophy, cognitive impairment, and seizures. The
condition available. The over-all goals of this project are to
obtain sufficient clinical information to understand the full-range of KAND symptoms; to determine how
mutations at diverse sites within the Kif1a motor domain impact clinical outcome; to understand the cellular and
developmental causes of the syndrome; and to identify small molecule reagents to treat it. Aim 1 will be to
define the natural history of KAND based on a rapidly increasing patient database and correlate clinical
severity and rate of progression with KIF1A genotype. Aim 2 will be to use advanced single molecule
biophysical and in vivo axonal transport approaches to determine the molecular and cellular consequences of
the Kif1a mutations. Aim3 will be to use Kif1a mutant mice to determine the longitudinal and cross-sectional
effects of the condition in a model organism, and to test more completely the role of BDNF in KAND and the
value of small molecule BDNF mimetics as KAND therapeutic agents. These studies are of great importance
for a number of reasons. They will dramatically extend our capability to identify and characterize rare
diseases. They will provide detailed insight into the molecular basis of a motor protein-associated disease.
They will provide extensive new information on the progression of the disease and the relationship of mutation
site to prognosis. And, they will take advantage of our new molecular and physiological insights into gene
function to develop targeted therapies.
can be fatal, and there is at present no treatment

Public health relevance
Mutations in the human KIF1A gene case a novel, rare neurological disease termed KAND. This proposal is to develop tools for gathering information on patients worldwide, determine how mutations identified in KIF1A cause neurodegenerative and brain developmental defects, and test novel therapeutic strategies in rat and mouse models.